Extended-release injectable gel for multi-day treatment of postoperative pain

Principal Investigator: Overstreet, Derek J.
Abstract
Sonoran Biosciences, Inc.
SBIR PA-23-230: Phase II
Over 14 million patients undergoing surgical procedures in the US annually require treatment of
moderate-to-severe postoperative pain lasting at least three days. The goal of this project is to enable opioid-
free treatment of pain in these patients using an injectable extended-release gel-forming formulation of
bupivacaine. Currently available alternatives have inadequate efficacy beyond 24 hr, leaving a window of time
when pain emerges and is frequently treated with opioids. Prescription opioid use poses serious risks of adverse
events to patients and is contributing to the ongoing nationwide opioid crisis. An extended-release local
anesthetic acting for three days or more would have considerable impact by simplifying postoperative recovery,
avoiding opioid-related adverse events, eliminating a common pathway to new and persistent opioid use, and
preventing unsafe storage of unused oral opioids.
Achieving analgesic efficacy using an extended-release local anesthetic requires supplying effective drug
concentrations in a volume of tissue surrounding the surgical site. Competing delivery technologies fail to
accomplish this, despite apparently well-timed release kinetics, due to one of two inherent limitations. First,
materials applied in the surgical wound space, such as organic polymer solutions and solid implants, must rely
on diffusion into surrounding tissue resulting in limited distribution. Alternatively, liquid-based systems such as
liposomes or prodrugs can be injected into a sufficient volume of tissue, but are susceptible to washout, leading
to off-target release.
We have developed a proprietary extended release carrier, SB Gel, which can be injected as an aqueous
solution and forms a soft gel upon contact with tissue. This combination of injectability and retention at the
injection site enables SB Gel to sustain a sufficient volume of tissue with effective local anesthetic concentrations
and avoid washout. In a Phase I SBIR project, we established the feasibility of SBG004, a formulation of SB Gel
with 4 wt% bupivacaine. Preliminary data indicate that SBG004 provides extended release in vivo for 7 days,
outperformed plain local anesthetics and current extended release competing products in soft and hard tissue
models of pain for 72-96 hr, and is well-tolerated both locally and systemically, including low Cmax at high doses.
We now propose to complete a Phase II project to continue the development of SBG004. In Aim 1, we
will collect further data comparing SBG004 against competing products, including data on weight-bearing
behavior after knee surgery and the concentrations of local anesthetic provided in surrounding tissue. In Aim 2,
we will conduct dose range-finding toxicity studies in two species to estimate a maximum tolerated dose and
inform the design of definitive IND-enabling studies. In Aim 3, we will manufacture a batch of SBG004 at 500
unit scale for use in IND-enabling studies. In Aim 4, we will complete a GLP toxicity study and a GLP
cardiopulmonary safety study which fulfill regulatory requirements and inform the design of future clinical studies.

Public health relevance
Principal Investigator: Overstreet, Derek J. Project Narrative Sonoran Biosciences, Inc. SBIR PA-23-230: Phase II Over 14,000,000 surgeries per year in the US cause substantial pain that can last three days or more after surgery. Current numbing agents applied during surgery only last up to one day, so patients often receive opioid drugs such as morphine to control their pain, which can cause harmful side effects and lead to abuse or addiction. This project seeks to develop a new gel- based product which releases a non-opioid numbing agent that treats pain for at least three days, enabling safe and reliable pain control while reducing the need for opioids.